Deep Analysis of Transcriptome to Understand the Genetics of Substance Use Disorders in Rats

Project Summary
Substance Use Disorders (SUDs) are a major public health problem for which new therapies are
urgently needed. A significant impediment to developing new treatments is our extremely limited
understanding of the biological basis of SUDs. Although animal models cannot recapitulate all
aspects of human SUDs, drugs of abuse produce several key behavioral phenomena in rodents,
including hedonically motivated drug self-administration, escalation of drug intake, tolerance,
withdrawal, and reinstatement of drug-seeking behavior. Rats are the preferred model system for
such studies, and Heterogeneous Stock (HS) rats are especially useful because they exhibit
highly variable behaviors such that some rats escalate drug intake and show compulsivity
whereas others do not. These behaviors are heritable and have already been extensively studied
using genome-wide association studies (GWAS).
GWAS in both humans and animals have identified heritable differences in gene expression as
the primary source of behavioral differences. Thus, there is an urgent need to understand
heritable differences in gene regulation in order to make sense of GWAS of behaviors like iv self-
administration of opioids. Many techniques have already been introduced to examine
transcriptome variation as a potential molecular mediator of GWAS signals. While these methods
have provided numerous mechanistic insights and testable hypotheses, they consider gene
expression changes as the only source of regulatory variation a. However, there is growing
evidence that other complex regulatory phenomena can contribute to heritable differences across
individuals. Here, we are proposing to improve molecular interpretation of GWAS results from
SUD-related phenotypes by expanding integrative genome and transcriptome analysis in rats to
a wide range of transcriptional phenotypes, including but not limited to transcript isoform usage,
lncRNA expression, alternative transcription start, and polyA sites, exon skipping, intron retention,
and RNA stability. Upon completing this project, we will have produced an unprecedented atlas
of variation in rat transcriptome as a mediator of SUD-relevant traits. We will integrate these
findings with SUD-related GWAS data to facilitate the identification of specific genes and provide
a molecular understanding of SUD that will identify new novel drug targets.

Public health relevance
Project Narrative/Public Health Relevance Studies of substance use disorder (SUD)-related traits that can be modeled in genetically diverse rats have the potential to enhance our understanding of human genetic susceptibility to SUD and may also identify new mechanisms that could be used to treat SUD. Understanding the role of gene expression is needed to fully understand the results of many studies that have already been performed. We propose applying sophisticated methods to vast amounts of existing RNA data to analyze behavioral data more comprehensively from rats that have been characterized for SUD-related traits such as voluntary consumption of cocaine, heroin, oxycodone, and nicotine.